Molecular Screening for Human Papilloma Virus (HPV) Associated with Cervical Cancers in LMIC Environments

Abstract
Human papillomavirus (HPV) causes cervical cancer, anogenital cancers, and a subset of oropharyngeal
cancers, with over 350,000 deaths per year globally. The World Health Organization guidelines for screening of
cervical cancer recommend using a strategy of screening with an HPV test instead of cytology or visual
inspection with acetic acid (VIA) for women with a priority age 30-49. In many underserved low- and middle-
income countries (LMICs), HPV testing may be available in cities but more limited in rural villages without ready
access to clinical laboratory facilities, due to cost and logistical barriers. To address this gap, we developed and
tested a portable, novel isothermal test called SPRINT-HPV (Simple, Portable, and Rapid Isothermal Nucleic-
acid Test) for the simultaneous detection of HPV16, HPV18, and nine other high-risk subtypes from cervical fluid.
SPRINT-HPV is specifically designed to be manufactured at a low reagent and equipment cost for point of care
(POC) settings. This SBIR Phase I proposal focuses on advancing SPRINT-HPV towards commercialization by
ensuring scalable, robust production and validating microfluidic cartridge performance for use in environments
without laboratory infrastructure. Scalable production of the SPRINT-HPV system will be engineered by using
steel-rule die cutting and injection molding for critical components. Each unit will be rigorously tested for thermal
stability, fluorescence detection, and reproducibility. A pilot production of microfluidic cartridges will be used to
assess performance of the SPRINT-HPV system with template nucleic acid and lyophilized reagents. Studies
will evaluate QA/QC testing, analytical performance, intra- and inter-assay variation, and stability of lyophilized
reagents. A pre-submission meeting with the US FDA will be conducted to obtain regulatory feedback for design
iteration and commercialization. Future Phase II efforts will focus on expanding QA/QC parameters, transitioning
to high-throughput cartridge manufacturing with blister pack fluidics, and conducting large-scale clinical
validation. We will aim for FDA and EU regulatory submissions for commercial deployment of SPRINT-HPV to
address the global need for cost-effective HPV screening in underserved regions.

Public health relevance
Narrative Cervical cancer is the fourth most common cancer in women and is driven by high-risk human papillomavirus (HR-HPV). We are further developing a portable, affordable, and accurate handheld system for rapid detection of HR-HPV to address critical gaps in cervical cancer prevention. Our device is operable in low-resource settings, where screening methods are costly or inaccessible.